Strengthening the Biomedical Data Science Training Program at Jackson State University

PROJECT SUMMARY
Jackson State University (JSU) proposes to develop a Biomedical Data Science Training Program (BDS-TP) to
train the next generation of scientists to address the monumental challenge associated with the curation,
integration, analysis, and interpretation of biomedical big data. This training program will strengthen the
biomedical research infrastructure of the newly established RCMI Center for Health Disparities Research at
JSU. With a special emphasis on the use and management of health disparities datasets representing multiple
levels and domains of influence articulated in the National Institute of Minority Health and Health Disparities
(NIMHD) Research Framework, the above-stated goal of the BDS-TP will be accomplished through two
specific aims that include: 1) Forster Collaborations between biomedical data scientists and BDS-TP
participants and RCHDR investigators. Approach: Identify and invite renowned scientists with expertise in
specific areas of BDS to serve as leaders/instructors of specific BSD-TP training modules, and facilitate
multidisciplinary collaborations; and 2) Build the capacity of JSU and other Mississippi’s HBCU-
Historically Black Colleges and Universities (Alcorn State University, Mississippi Valley State
University, and Tugaloo College) in biomedical data science. Approach: Organize Train-the-Trainer
bootcamps to train the STEM (science, technology, engineering and technology) faculty and post-doctoral
research fellows on how to apply cutting-edge data science techniques to different biomedical data types, how
to use Galaxy and computational resources like Jupyter Hub, and coding with R, Python, and other data
science tools such R-Studio, Galaxy, or Carpentries; and organize Codeathons focused on specific biomedical
topics using various types of datasets. The achievement of these specific aims will significantly enhance the
data science skills of program participants, ranging from basic best practices in data collection, curation and
analysis to complex computational techniques like machine learning and artificial intelligence that are critical
for advancing the science of minority health and health disparities.

Public health relevance
PROJECT NARRATIVE Jackson State University (JSU) proposes to develop a Biomedical Data Science Training Program (BDS-TP) to train the next generation of scientists to address the monumental challenge associated with the curation, integration, analysis, and interpretation of biomedical big data. This training program will strengthen the biomedical research infrastructure of the RCMI Center for Health Disparities Research at JSU. Achieving these specific aims will significantly enhance the data science skills of program participants, and enhance their capabilities to foster health disparities research using big data.